Improving Survivorship Care for Adolescents and Young Adults: a Mixed Methods Study of Alignment with the National Standards for Survivorship Care

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as "NOT-CA-
24-041”. This proposal aims to investigate the level of alignment between the survivorship services provided by
the Fred Hutchinson Cancer Center (FHCC) and the National Standards for Survivorship Care, and to assess
the current status of survivorship care at FHCC for patients diagnosed with cancer as adolescents or young
adults (AYA, ages 15-39 yrs). We will determine the utilization rates and barriers or facilitators to receiving
survivorship care among AYA survivors who were eligible for the parent grant (U01 CA246659). The parent
grant focuses on AYA survivors and tests the INSPIRE–Adolescent and Young Adult program, which
incorporates a mobile app/website and telehealth care to reduce distress and improve healthcare adherence
among AYA survivors across five US centers. The proposed supplement aims to expand the assessment of
survivorship care beyond distress and adherence, evaluating survivorship care comprehensively. This proposal
includes a mixed-methods design. The first aim will compare the alignment of current survivorship services
with the National Standards for Cancer Survivorship Care. The second aim will examine utilization rates of the
Survivorship Clinic and supportive care services for those AYA survivors who were screened and determined to
be eligible to participate in the parent grant. The third aim will approach a subset of AYA survivors who have
agreed to further contact (95% of them have agreed) to perform a qualitative study using semi-structured
interviews to assess barriers and facilitators to attending the Survivorship Clinic and/or receipt of survivorship
focused supportive care services. This data generated from this administrative supplement will offer the
opportunity to comprehensively examine the current state of survivorship care service being provided to a
generally underserved population of cancer survivors—those diagnosed and treated as AYAs. Gaps in
meeting national standards and barriers identified during the qualitative interviews will be brought forth to
Cancer Center leadership so that efforts to enhance care delivery can be implemented with a goal that all AYA
survivors have the opportunity to receive care that is concordant with national standards so that that their late
and long-term physical, financial, social and emotional needs can be met, and strategies can be implemented
to reduce barriers. Additionally, the findings will be disseminated to advance survivorship care practices at
other cancer centers.

Public health relevance
PROJECT NARRATIVE This proposal aims to investigate the level of alignment between the survivorship services provided by a comprehensive cancer center and the National Standards for Survivorship Care. Additionally, it will analyze the utilization rates of the Survivorship Clinic among a sample of adolescent and young adult cancer survivors who were initially eligible to take part in a randomized trial involving a mobile app and website designed to reduce distress and enhance adherence to healthcare in the parent grant. Lastly, qualitative interviews will be conducted with a subset of AYA participants to explore their experiences and the barriers and facilitators they encountered in accessing survivorship-focused care.